Decoding cortical Notch signaling and morphogenic instruction at cell-cell interfaces

Project Summary/Abstract
The coordination of genetic programs and the physical organization of cells sculpt developing tissues, drive
regeneration and, when dysregulated, facilitate disease. How these two processes are coordinated in space and
time is poorly understood. Cell-cell interfaces are important organizing centers for morphogenic instruction. Here
signals influencing gene expression that ultimately dictate cell fate decisions are integrated with changes in cell
mechanics and, together, are necessary to build and maintain multicellular architectures. With an appreciation
that gene regulatory networks and mechanics conspire at cell-cell interfaces to instruct morphogenic processes,
an emerging challenge is to experimentally define the details of their intersectional operations in diverse
morphogenic contexts. One intriguing example of cell-cell communication is the ubiquitously important Notch
receptor pathway which has the intrinsic capacity to regulate both cell mechanics and gene expression, yet
mechanisms of these distinct activities are unclear. As a postdoctoral fellow, the PI developed biomimetic
microfluidic models of human tissues that were employed to identify several new mechanisms controlling 3D
multicellular behavior operating at cell-cell and cell-extracellular matrix interfaces. The PI discovered that the
highly conserved Notch family of receptors possess a previously undescribed cortical signaling function that
permits Notch to connect changes in cell mechanics to transcriptional output. As an independent laboratory, the
Kutys Lab has completed the first investigation into cortical Notch signaling in epithelial tissues and has identified
morphogenic consequences and previously unappreciated signaling mechanisms. Over the next five years, the
goal of the Kutys Lab is to continue its multidisciplinary approach of developing next generation biomimetic
human tissue systems, molecular technologies, and microscopy-based methods to define the coordination of
morphogenic behavior and signaling at cell adhesive interfaces. We will focus these efforts in three Areas: 1)
engineering new tools to deeply understand how the cortical Notch pathway regulates signaling and adhesion
mechanics in epithelia and the contexts in which it is invoked to regulate important biological processes in vitro
and in vivo, 2) comprehensively defining how Notch receptor localization and activation are influenced by
biophysical interactions with cell-cell adhesions and cortical actin during epithelial crowding and in endothelial
cells exposed to shear stress, and 3) integrating proteomic approaches with 3D biomimetic systems to broadly
profile and dissect how tissue architecture influences molecular control systems operating at cell-cell interfaces.
The results of this research and the integration of the enabling technologies will contribute to the overall
objectives of my research program. Together, these studies will offer fundamental insight into an important new
arm of Notch signaling, how cell-cell adhesions might be dynamically regulated, and the molecular basis for how
transcriptional and adhesive programs might be coordinated within complex 3D tissues.

Public health relevance
Project Narrative Tissue structure and function requires coordination between the dynamic physical organization of cells and the genetic programs controlling cell phenotype. Our understanding of this coordination is poor due to limitations of existing experimental systems, but critically needed to understand development and combat pathologies such as cancer and cardiovascular disease. This proposal is designed to contribute new molecular and platform technologies that will uncover fundamental molecular control systems at cell-cell interfaces that orchestrate these physical and genetic processes.